PKA & PKC Targeting Mechanisms (Program Project)

* Description of computer facilities is in need of updating. Presumably the PowerMac is no longer in use. 3. Qualifications of the Program Director and other Personnel: Strengths * The Director and other personnel seem very well qualified to direct and run this core. 4. Appropriateness of the Timetable: Strengths * Approach to taking on work seems fine for this type of core. Weaknesses * No specific timetable described (or needed).

Public health relevance
Our program project addresses the fundamental mechanisms in insulin resistance that accompanies diabetes and metabolic syndrome. With approximately one third of the US population considered obese, including an increasing proportion of children, these two diseases have reached epidemic proportions. Thus, our multi-faceted approach to address the underlying molecular mechanisms driving the assembly and dissociation of protein scaffolds during insulin resistance/insufficiency will provide novel insights into the organization of signaling networks that regulate metabolic syndrome and has the potential to identify novel targets for therapeutic intervention.